IMPROVE

Expansion of Clinical Trials Network Research Capacity to Address Overdose Mortality in Pregnant and
Post-Partum Women with OUD
ABSTRACT/PROJECT SUMMARY
From 2010 to 2017, opioid-related maternal deaths increased by 220%. Drug overdose deaths,
par�cularly deaths involving synthe�c opioids like fentanyl, reached record highs in 2020 and 2021; drug
overdose is now a leading cause of pregnancy-associated mortality in the United States, especially
among women of color and those living in rural areas. During pregnancy, u�liza�on of medica�ons for
the treatment of opioid use disorder (MOUD) (buprenorphine or methadone) have been associated with
improvements in prenatal care adherence and pregnancy outcomes, including lower rates of preterm
birth and low birth weight and reduc�ons in maternal relapse and overdose. Prior research has iden�ﬁed
health dispari�es in MOUD ini�a�on, consistent u�liza�on, and treatment adherence among
underserved pregnant and postpartum people with OUD. However, recent na�onal trends in pregnancy-
associated overdose mortality are under-characterized, and there is a need to beter understand key
facilitators and barriers to treatment engagement for these under-served women with OUD.
This proposal seeks supplemental funds to u�lize the inves�gators and resources of the CTN0080 study
to conduct research to address overdose preven�on and learn about persistent barriers to treatment
among Hispanic, Black, and Na�ve American pregnant and post-partum (PP) women, as well as PP
women living in rural areas of the US. The CTN is currently suppor�ng CTN0080, a large mul�-site clinical
trial (13 sites) led by Dr. T. John Winhusen of the CTN Ohio Valley Node that evaluates the compara�ve
eﬀec�veness of buprenorphine formula�ons in PP women. This proposal requests supplemental funding
to conduct four projects that will target opioid overdose preven�on, as well as learn about barriers and
facilitators regarding treatment engagement in PP women, especially PP of color and living in rural areas.
Most projects will involve pa�ent and/or community advisors to assist with study procedures and
approaches.

Public health relevance
Expansion of Clinical Trials Network Research Capacity to Address Overdose Mortality in Pregnant and Post-Partum Individuals with OUD PROJECT NARRATIVE This expansion project will encompass the following four projects, aimed at opioid overdose prevention, learning about barriers and facilitators regarding treatment and research engagement in pregnant and post-partum individuals (PPI) with OUD, especially PPI of color and those living in rural areas. The IMPROVE expansion project teams will work with the IMPROVE COE Implementation Hub to disseminate any products generated, which will focus on recruitment, retention, and engagement of pregnant/postpartum women with OUD. Project 1: Personally-Tailored Opioid-overdose and Medication for opioid use disorder (MOUD) Education (TOME) for pregnant and postpartum persons in MOUD: A pilot randomized trial (TOME trial) This study plans to evaluate the benefit of personally-tailored opioid overdose and medication for opioid use disorder education in pregnant and post-partum individuals receiving medication for opioid use disorder. Approximately 120 PP will be randomized in a 1:1 ratio to TOME or control balancing on site. TOME participants will receive a 15-minute intervention in which a trained research staff member reviews personal feedback reports with the recipient to provide information on the items missed on the opioid overdose (OOD) and MOUD knowledge assessment. Control participants will receive SAMHSA handouts about OOD and MOUD. Project 2: Successful Recruitment and Retention in a Randomized Controlled Trial of Pregnant People with Opioid Use Disorder (SUCCESS STUDY) This study plans to identify currents strategies, facilitators and challenges in recruitment and retention among sites in the MOMs trial. This project will conduct surveys, focus groups and interviews with research staff and individuals currently enrolled in the study. This project will develop a manual with recommendations for strategies and approach for trials to recruit and retain PP with OUD in RCTs. Project 3: Promoting Research with Mothers receiving OUD Treatment; a focus on Equity (PRoMOTE) This study plans to understand patient and provider perspectives and key facilitators and barriers to treatment engagement for women in color and living in rural areas. The study will invite patients and providers to participate in surveys and focus interviews; the patient interviews will be completed by mothers in recovery (trained and mentored on interviewing skills) who have expertise in interviewing women of color and women living in rural areas with SUD. The studies will seek to understand the needs of pregnant women who use opioids (including fentanyl) from diverse communities that include communities with differing laws regarding reproductive health. The data will assist in future outreach and engagement in MOUD. Project 4: Improved Messaging Strategies for MOUD for Underserved Populations of Pregnant and Postpartum Individuals with OUD. This project plans to develop innovative and meaningful education/messaging strategies regarding (1) addiction disease & NOWS, (2) the role of medications in the management of OUD and overdose prevention, (3) stigma and health system mistrust, and (4) PP persons rights to treatment. This project plans to involve researchers, patients, and community advisors to develop products specific to the target population (Hispanic, Black, and Native PP women, and those living in rural areas).